MAVEN: Developing Diverse Senior Scientists Leaders

Increasing the diversity of the scientific workforce at the senior level is essential to facilitating the nation's
research agenda,1 to training future generations of scientists,2 to advising public health policy makers, to
enriching scientific approaches, and to reducing national health disparities.1 Requisite to this goal of
diversity at the senior scientist level is providing a greater number of underrepresented scientists with key
skills to navigate to a productive, engaging, and rewarding senior faculty position and science portfolio. The
long-term objective of the MAVEN program is to expand the national pool of qualified women and minority
candidates for senior scientist positions across all NIGMS areas of science. We intend to create a self-
sustaining community committed to inclusive excellence in science. We will do so by adapting best
education practices from other industries in executive leadership, strategic career planning, and institution
culture change, to create a sustainable, but intensive program with objective evaluation metrics. Our
innovations include proactive invitations to apply and randomization of those applicants to a control group or
to program attendance. Four cohorts of scientists will be invited to attend MAVEN, two 5-day institutes
focused on senior scientist career planning, respect-based leadership, evidence-based mentoring,
organizational culture problem solving, transparency and Open Science, interdisciplinary team collaboration
and inclusivity, effective science thought leadership and public engagement with science. These residential
summer institutes will be comprised of didactics, discussions, and interactive individual and team-based
activities. Between the institutes there will be 10 months of mentorship, networking, and conduct of
institutional responsible conduct of research projects. Target program participants are scientists 10-15 years
from their final training, who identify as belonging to an ethnicity, race or gender under-represented at the
senior levels of faculty, and who currently hold one or more NIGMS-funded R01 or equivalent grants. To
achieve the MAVEN long-term objective, MAVEN scientists will be provided the skills to attain: 1) increased
career satisfaction (primary outcome); 2) peak academic productivity; 3) expanded scientific networks; and
4) leadership ascension. Program success will be evaluated by comparison of the control group to MAVEN
scientists for change in career satisfaction scores and a blended Major Educational Score Index comprised
of h-index, relative citation ratio, number of publications in journals with an impact factor > 5, and annual
federal grant dollar amounts. We will also explore changes to professional scientific network size and the
leadership ascension between the two groups, tested quantitatively.
If our scientific leaders and role models are diverse, we stand to benefit from enrichment of the pool of
future investigators, the broader perspective in research agenda prioritization, the greater success in
recruiting diverse research participants, and the enhanced ability to reduce health disparities.

Public health relevance
To ensure the relevance and high quality of NIGMS research, it is essential that senior scientists are satisfied with, and thriving in, their careers and their future, and are an adequate representation of our society according to gender, race/ethnicity, economic, and cultural background. If our leaders and role models are diverse, we stand to benefit from enrichment of the pool of future investigators, broader perspective in research agenda prioritization, greater success in recruiting diverse research participants, and ultimately enhanced ability to reduce health disparities. By providing intensive training to overcome the final transition barrier to attaining science leadership, we will support the goal of NIGMS and of NIH to achieve sustainable transformation in scientific workforce diversity at all levels, including the most senior one.